Cholesterol Regulation of EGFR-dependent Vasoconstriction in Chronic Hypoxia-induced Pulmonary Hypertension

Project Summary
Chronic Hypoxia (CH)-induced pulmonary hypertension (PH) is a significant source of morbidity and
mortality in patients with chronic obstructive pulmonary diseases. It is widely recognized that vasoconstriction
is a critical mediator of PH, although the mechanisms involved are poorly understood. Our previous studies
have demonstrated that enhanced vasoconstrictor sensitivity following CH involves a requisite reduction in
pulmonary arterial smooth muscle cell (PASMC) membrane cholesterol content. We have also demonstrated
that CH augments vasoconstrictor reactivity by a switch in signaling from primarily calcium-dependent
mechanisms to a Ca2+ sensitization pathway that involves the epidermal growth factor receptor (EGFR) and
reactive oxygen species (ROS). However, the mechanisms by which CH decreases membrane cholesterol and
how this unmasks EGFR-dependent vasoconstriction has yet to be assessed.
The proposed studies will investigate the central hypothesis that coupling of vasoconstrictor stimuli to
EGFR signaling following CH promotes PASMC hypercontractility through a ROS-dependent decrease in
membrane cholesterol. To test this hypothesis, protocols will employ both in vivo and in vitro approaches using
a variety of experimental preparations from molecular and single cell imaging studies to video-microscopy of
pressurized small pulmonary arteries using a rat model of CH-induced PH.
We plan to pursue the following specific aims:
Specific Aim 1: Determine the mechanism by which CH decreases PASMC membrane cholesterol.
Hypothesis: Elevated ROS production during CH diminishes membrane cholesterol.
Specific Aim 2: Determine the mechanism by which decreased PASMC membrane cholesterol augments
vasoconstrictor sensitivity following CH.
Hypothesis: Decreased PASMC membrane cholesterol in response to CH unmasks EGFR-dependent
pulmonary vasoconstriction through regulation of NOX2 and Rac1.
The applicant will be immersed in a rich training environment in the Vascular Physiology Group at the UNM
School of Medicine through a unique, multi-sponsor mentoring team that will facilitate his research training in
defining novel mechanisms by which ROS alter the PASMC membrane microenvironment to affect cellular
function in CH-induced PH. The proposed training plan will afford the applicant intensive training experiences
in a variety of new experimental approaches, refinement of his oral and written communication skills, and
professional development training that will aid him in achieving his goal as an independent, academic
physician-scientist in pulmonary research.

Public health relevance
Project Narrative Chronic obstructive pulmonary diseases (COPD) such as emphysema and chronic bronchitis are established major causes of mortality and morbidity in the U.S. Such disease states cause poor oxygenation of the blood (hypoxia), and the resultant pulmonary hypertension leads to right heart failure and mortality in humans. Planned studies are relevant to the mission of the National Heart, Lung, and Blood Institute because they will mechanistically examine the contribution of a novel intracellular signaling pathway to the vasoconstrictor component of pulmonary hypertension in a rat model of COPD, and have potential to reveal new therapeutic targets for these disorders.